LV dyssynchrony and fibroblast activation in PVC-induced Cardiomyopathy

Background. Premature ventricular contractions (PVCs) are the most frequent ventricular arrhythmia and are
highly prevalent in the elderly. Persistent PVCs are known to cause an LV systolic dysfunction, referred as
PVC-induced cardiomyopathy (PVC-CM). Triggers and molecular mechanisms behind maladaptive responses
of the heart subjected to frequent PVCs are elusive to identify, but recently we have done significant progress
understanding structural and functional changes happening in the left ventricle (LV) of PVC-CM animal models
(see preliminary results). We postulate that LV dyssynchrony is the key trigger to activate fibroblast resident in
the heart. Activated fibroblasts (also called myofibroblasts) can command remodeling of the extracellular matrix
(diffuse fibrosis), release cytokines and neurohumoral factors that can affect cardiac myocyte structure
(hypertrophy) and function (decreased ejection fraction).
Hypothesis: Our working hypothesis is that mechanical stress though LV dyssynchrony promotes fibroblast
activation involving the activation of the RhoA/HIPPO pathway. Activated fibroblasts (myofibroblasts) release
cytokines promoting tissue remodeling (fibrosis), and these factors have a paracrine effect on cardiac myocytes
leading to altering function/expression of proteins key for Ca2+ cycling, ultimately impairing contraction.
Aim 1: Determine the activation level of the RhoA/HIPPO pathway in the whole tissue, and specifically in
fibroblasts using hybridization chain reaction (HCR) immunohistochemistry (IHC) and HCR-RNA-FISH
technologies (in situ techniques) together with artificial intelligence based-image processing quantification for
high throughput analysis.
AIM 2: Cytokine markers of fibroblast activation (TGFβ1,2,3, IL6 and IL-1β) will be determined using qPCR and
WB for global changes, and HCR-RNA-FISH technology will used for in situ determination of specific cell type
where expression of these markers is upregulated.
AIM 3: Proteins involved in excitation contraction (EC) coupling such as RyR2 and phospho-RyR2, L-type Ca2+
channel, Rad and phospho-Rad, NCX, SERCA2a, phospholamban (PLB) and phospho-PLB, and calsequestrin
will be determined via WB, and from Ca2+ dynamics results obtained from the parent grant, mathematical
simulations will assess the role of Ca2+ handling on contractility and the likelihood of repolarization abnormalities
in PVC-CM.
Methods. Swine will be implanted with modified pacemakers and will be randomized in 3 cohorts: 1) Sham group
(normal rhythm, no arrhythmias), 2) premature atrial contractions (PAC) group having post-extrasystolic
potentiation (PESP) but no LV dyssynchrony, 3) PVC group having both PESP and LV dyssynchrony. Using
echocardiography, PESP and LV dyssynchrony will be quantified along with changes in LVEF during 12 weeks
for each animal. Thus, these changes will be correlated with biochemical changes observed in Aims 1, 2, and 3
for each animal. These correlations will provide evidence of the relevance of PESP and LV dyssynchrony in
fibroblast activation and its downstream deleterious effects. Combining measurements of protein
expression/regulation with “in silico” assays, we will identify changes in contractility and assess risk
for repolarization abnormalities linked to Ca2+ dynamics observed in PVC-CM.
Significance. This proposal will identify the role and molecular mechanisms of fibroblast activation by
mechanical stress associated with LV dyssynchrony during PVCs, and use mathematical models to assess the
role of Ca2+ dynamics and repolarization in PVC-CM. At the end of this project, potential molecular targets will
be identified, directing future preclinical studies for therapeutic intervention.

Public health relevance
Premature heart beats, so called “Premature Ventricular Contractions” (PVCs), are commonly seen in patients with heart failure. PVCs have been recognized to debilitate the heart and cause heart failure, called "PVC-induced cardiomyopathy" (PVC-CM) with significant financial burden to Veterans if untreated. As our PVC-CM model in the swine moves forward, this diversity supplemental funding will confirm and validate inflammatory markers and molecular mechanisms of fibroblast activation by mechanical stress during PVCs (Dr. Eltit, Hispanic scientist). In addition, Dr. Eason (disabled biomedical engineer) will introduce for the first-time mathematical models to assess Ca2+ dynamics and repolarization in PVC-CM. We anticipate that this study will help us understand the mechanism of PVC-CM and find specific molecular targets, leading to better prevention and treatment of PVC-CM and identification of high-risk patients with significant impact in heart failure admission, mortality, and VA healthcare spending.